Structural Cell Biology of DNA Repair Machines

SUMMARY
DNA repair maintains genome stability to prevent cancer and provides resistance to cancer treatments; yet, DNA
repair defects lead to cancer-causing mutations and are an Achilles heel for cancer-targeted treatments.
Structural Cell Biology of DNA Repair Machines 5 (SBDR-5) coordinates leaders in DNA repair (DR) to work
together synergistically for comprehensive mechanistic and structural knowledge of DR processes. Four
interacting Projects (P1-4) target DR pathways implicated in cancer etiology, treatment, and resistance:
P1 investigates repair of base lesions from chemotherapy including a paradigm-shifting model for RNA damage
responses to alkylating agents.
P2 defines inter-locking pathways for repair of dsDNA breaks (DSBs), a result of radiation therapy as well as
replication encounters with DNA lesions.
P3 examines PARylation-mediated phase condensates and their impacts on DR for PARP inhibitor therapies.
P4 determines mechanisms in replication fork stress responses, key consequences of many cancer treatments.
Our highest priorities are to solve actionable structures in each Project and apply our teamwork to biochemically
and biologically test molecular insights and hypotheses based on our structures. Two experimental Cores will
enable efficient preparation of DR assemblies and determination of their structures. Removing bottlenecks within
individual laboratories and promoting collaborative efforts, SBDR Projects and Cores together enable a
comprehensive cross-pathway knowledge of dynamic multi-functional DR machines – knowledge best achieved
through multi-disciplinary approaches and concerted efforts by multiple groups. Our four Program aims are:
1) Determine actionable and biologically-validated structures of DR complexes, interfaces, and conformations.
2) Dissect multi-functionality of DR machineries tested by structure-based design of separation-of-function
mutations and chemical inhibitors to inform on predicted therapeutic sensitivity and development of resistance.
3) Define DR pathway interactions and crosstalk with replication dynamics to delineate DR pathway outcomes.
4) Discover synthetic lethality from mutations or chemical agents that target specific DR activities and which
become essential only in conjunction with another DR defect to promote successful therapeutic interventions.
SBDR will provide lasting structure-based knowledge for interpretation of mutations from The Cancer Genome
Atlas and of mechanisms that inform system level knockout and knockdown correlations. Through concerted
efforts, SBDR-5 will establish biologically-validated structures and synthetic lethality relationships with durable
biological and medical utility. We will share constructs, mutants, inhibitors, data, and technologies to enhance
synergy, reproducibility, and efficiency. Our target structures and mechanisms are both challenging and timely:
the expected results will have indelible impacts on ongoing NIH research in other labs, on assessment of cancer
genome data, and on knowledge for treatment strategies in ongoing clinical and preclinical trials of DR inhibitors.

Public health relevance
NARRATIVE, OVERALL DNA repair structures and mechanisms are an essential component to understanding and treating cancer. Defects in DNA repair pathways, such as mutagenic or genetic deficiencies can predispose cells to initiate cancer. DNA repair can also work antagonistically against cancer treatments that damage DNA, and in such cases, known mutations of DNA repair proteins in specific cancer cells provide opportunities to develop effective treatments. SBDR-5 brings together the top laboratories in DNA repair through multi-disciplinary collaborations to define the complex and dynamic network of DNA repair machines and to develop an actionable, quantitative and mechanistic knowledge of DNA repair machines, pathways and intersections with DNA replication and other DNA-related processes to aid prediction and intervention for cancer biology.